NIAAA Repository/Screening Database Management and Research

As of this report, the NIAAA Repository/Natural History Database includes phenotype and/or genomic data on 3742 individuals. Phenotype data include psychiatric diagnoses, a variety of alcohol-related assessments and measures including lifetime and recent consumption and alcohol response phenotypes, personality and impulsivity measures, depression and anxiety symptoms, current and early life stress and trauma, aggression, suicidality, smoking, IQ, sleep quality, pain, and overall quality of life. Laboratory/biochemical measures are also available. Genomic data include 1) large-scale single nucleotide polymorphism (SNP) genotyping performed using Illumina arrays, 2) exome sequencing of a subset of subjects, both via a partnership between the Clinical Core Laboratory of the OCD, and the Laboratory of Neurogenetics (NIAAA), and 3) DNA methylation data for a subset of subjects via a partnership with the Laboratory of Neurogenetics.

All NIAAA PIs and their research staff are encouraged to submit data requests in order to conduct research projects and analyses using the shared NIAAA Repository/Natural History Database. Projects are logged and the status is tracked from initial request to manuscript publication. In addition, Human and Genomic data are shared via BTRIS and other mechanisms, including collaboration with NIH-supported consortia (PGC Alcoholism, ENIGMA) to ensure data sharing.

I. Projects (7) resulting in manuscripts published within the past year:

Electrocardiogram and other cardiovascular indicators of at-risk alcohol drinking

Immunoglobulin levels in alcohol use disorder and their association with comorbid major depressive disorder and chronic stress

Phenotypic differences between comorbid AUD/PTSD and individuals with only AUD or only PTSD, and effects of childhood trauma

Comparison of resting state functional connectivity, alcohol consumption patterns, and CASE behavior as a function of CHRNA5 genotype

The relationship between body mass index and level of response to alcohol

Interactions between the UPPS-P impulsivity facets and alcohol related outcomes, including suicidality.

The buffering role of resilience in the association between multidimensional impulsivity and problematic drinking

II. Projects (3) resulting in manuscript submissions, revisions, or publications in press, within the past year:

Copy Number profiling and Alcohol Use Disorder (AUD)

Cardiometabolic factors in Alcohol Use Disorders

The impact of trauma timing and load on brain-behavioral measures of Alcohol Use Disorder

III. Projects (8) with manuscripts in preparation:

Connor-Davidson Resilience Scale (CDRS) and other measures of resilience: association with childhood trauma, alcohol-related outcomes and psychopathology

Characterization of drinking patterns in alcohol use disorder by Timeline Follow-Back variability analysis: association with craving, other substance use, psychopathology, and alcohol-related liver conditions

Clinical Pain Severity in AUD: Impact of Childhood Trauma and Current Stress, and an Examination of Sex Differences. Data analyses for a second paper are ongoing.

Correlation of polysubstance use with severity of alcohol withdrawal

Prevalence of oral health and smoking, and the relationship between stress, early life events, and oral health in a sample of treatment-seeking individuals with alcohol use disorder

Interaction of alcohol use disorder and genetic predisposition on iron metabolism and related outcomes

investigating the AIF1 gene: unraveling its role in tissue inflammation, alcohol abuse, and potential links to lupus

Association of Amygdalar Genes to Negative Emotionality in AUD and other Addictive Disorders

IV. Ongoing projects (14) still in progress:

Individual differences of Taste Receptor Genes and their association with alcohol-and food-related phenotypes and behaviors. Data analyses are ongoing.

Analysis of weight trends and micronutrient stores in patients admitted to an inpatient alcohol rehabilitation program. Data analyses are ongoing.

Differences between those with only AUD and those with AUD and depression with an emphasis on the ANA framework. Poster presented at APA, follow-up analyses ongoing.

Trends in alcohol use and misuse and related phenotypes: NIAAA natural history protocols, 2005 to the present. Poster presented at RSA, data analyses ongoing.

Modeling patterns of adulthood life events and their associations with mental health, well-being, and alcohol-related outcomes

Adverse childhood experiences, psychiatric comorbidity, and the response to stress and alcohol cues in individuals seeking treatment for alcohol use disorder. Poster presented at ACNP.

Role of metal ion transporter ZIP8 in alcohol related behaviors. Data analyses ongoing.

Alcohol sensitivity associated genome-wide DNA methylation patterns in alcohol dependent and non-dependent subjects. Data analyses ongoing.

Examining the Interaction of Early Life Stress with Polygenic Risk Score on Alcohol Use Outcomes. Data analyses ongoing.

Correlation of albumin with other clinical parameters after heavy alcohol consumption and during inpatient treatment. Data analyses ongoing.

Trajectory of non-invasive markers of fibrosis. Data analyses ongoing.

Phenome-wide association studies (PheWAS) of CHRNA5–A3–B4 and SLC39A8 gene variants and investigation of genetic pleiotropy of alcohol and nicotine. Data analyses ongoing.

Participant retention during the transition from inpatient to outpatient AUD treatment: a machine learning project. Data analyses ongoing.

Genetic and familial risk factors underlying risk of AUD and related comorbidities. Data analyses ongoing.

V. New projects (8) initiated within the past year:

Exploring the Intersection of Alcohol Use Disorder and Recidivism

Exome-Wide Variant analysis of Alcohol Response Phenotypes: Withdrawal, flushing and self-rating of effects of ethanol (SRE)

Exploring Psychiatric Comorbidity Patterns through Overlapping Disorder Symptomology and PGS

Biological markers of allostatic load in individuals with and without alcohol use disorder

Pain Trajectories in Treatment-Seeking AUD Patients with Chronic Musculoskeletal and Connective Tissue Conditions

Prescription analysis for Alcohol Use Disorder and alcohol-related disorders

Investigating associations and prevalence of food addiction in individuals with Alcohol use disorder

Investigating how alcohol alters LH levels and the impact of these changes on cardiovascular disease risk in individuals with and without Alcohol Use Disorder

VI. Other Progress

A new collaboration was set up with Dr. Jaymin Upadhyay of Boston Children’s Hospital/Harvard Medical School, to study physical and emotional pain during the protracted withdrawal state of alcohol use disorder.

A new collaboration was set up with Dr. Vatsalya Vatsalya of the University of Louisville, to investigate how cytokines measured in CSF characterize the clinical domains of alcohol use disorder.